Gut microbes modulate immune pathways in intestinal stem cells to influence their lineage

An increasing number of epidemiological studies suggest that intestinal microbes are not only central to
maintaining host health, but also constitute etiological factors for the initiation and progression of diseases of the
intestinal tract. However, the mechanisms by which microbes affect intestinal health remain largely unknown.
Using a powerful genetic model organism, Drosophila melanogaster, we have recently shown that microbes not
only alter intestinal stem cell (ISC) proliferation, but also modulate the relative proportions of differentiated cell
types in the epithelium. Importantly, we found that pathogens promote an enteroendocrine (EE) fate while non-
pathogenic microbes promote an enterocyte (EC) fate, suggesting that pathogenic and non-pathogenic microbes
influence ISC lineage in an opposing manner. Based on these results, and from our previous studies, we
hypothesize that gut microbes modulate immune signaling pathways in ISCs to influence their lineage
decisions. To test this hypothesis, we propose the following specific aims: Aim 1: We will determine the
microbial characteristics (immunogenicity, virulence/damage) that modulate the cellular composition of the gut
epithelium in both Drosophila and murine enteroids. In parallel, we will determine the relative contributions of cell
loss, ISC proliferation and differentiation to this process. Aim 2: We will characterize how a classical immune
pathway, the Imd/Relish pathway (NFκB homologue), acts in Drosophila ISCs and murine enteroids to influence
differentiation in response to gut microbes. We will first identify ISC-specific Relish target genes using a
combination of cell type-specific transcriptomics and targeted DamID (TaDa). We will then analyze how the
Imd/Relish pathway interacts with other gene networks known to control ISC differentiation. Our studies will
therefore demonstrate a new role for Imd/Relish that goes beyond the control of immune effectors and provide
mechanistic insight into how this pathway alters stem cell lineage and epithelial composition. Aim 3: We will
investigate how activation of the Janus kinase (JAK)-signal transducer of activator (STAT) pathway triggers EE
fate commitment in Drosophila ISCs and murine enteroids. We will identify direct and indirect target genes of
STAT in order to characterize downstream mechanisms and delineate the impact that JAK-STAT signaling has
on ISC differentiation. Finally, we aim to clarify how the interaction between the JAK-STAT and Imd/Relish
pathways determines the opposite ISC fates produced in the gut by pathogenic and non-pathogenic microbes.
Outcomes of this research will improve our understanding of how the microbiota alters intestinal homeostasis in
health and disease and demonstrate that different gut microbes (pathogenic vs non-pathogenic) alter gut
epithelial composition by differentially modulating ISC differentiation. We will also identify a new role for pathways
classically defined as immune pathways in affecting ISC differentiation, providing new mechanistic insight into
how ISCs respond to their microbial environment. The mechanistic principles identified in our study will therefore
pave the way to a better understanding of diseases of gut origin and potentiate the development of new therapies.

Public health relevance
Microbial and host genetic factors contribute to the progression of intestinal diseases affecting millions in the USA growing body of evidence indicates that gut microbes influence intestinal stem cell activity, and thus play important roles in maintaining healthy gut function. From this proposed study, we will analyze in depth how conserved microbial characteristics (i.e. immunogenicity, virulence) and host pathways determine intestinal stem cell behavior in response to pathogenic versus non-pathogenic gut microbes.